Outreach to Reduce Disparities in Depression Treatment Initiation

Failure to initiate treatment is a major gap in care for depression - A recent Mental Health Research
Network (MHRN) study involving more than 240,000 patients in 5 health systems with a new diagnosis of
depression in primary care found that only about a third (36%) had completed a psychotherapy visit or filled a
prescription for antidepressant medication within 90 days of a new depression diagnosis.
Large racial and ethnic disparities in depression treatment initiation exist – In that MHRN study the odds
of Asians, Blacks and Hispanics initiating treatment were 30% lower than for Non-Hispanic Whites.
Previous research has focused on care after treatment initiation – Collaborative care and care
management programs can reduce disparities, improving outcomes among traditionally under-served racial
and ethnic groups. This work, however, has usually focused on those who have already initiated treatment.
Interventions improve treatment initiation must accommodate diversity of patient experience and
preferences –Underserved racial and ethnic groups may prefer psychotherapy over medication and may also
prefer alternative treatments or alternative care providers. One size of depression treatment does not fit all.
eHealth technologies have the potential to address failures in treatment initiation – Previous research by
MHRN investigators and others demonstrates that online messaging and other telehealth technologies can
effectively and efficiently improve depression treatment adherence. These interventions, however, have
focused on adherence after treatment initiation and have been tested primarily in non-Hispanic white patients.
Proposed trial: This pilot study will refine, adapt and test an outreach intervention to improve depression
treatment initiation among patients recently receiving a new diagnosis of depression in primary care. Focusing
on African American, Asian, Native Hawaiian/Pacific Islander and Hispanic patients, the study will leverage
existing MHRN work to implement an automated outreach program with follow-up care facilitation by mental
health clinicians. The intervention will utilize analytic and technological expertise developed by the MHRN to
rapidly identify patients, send outreach messages, conduct assessments and facilitate care for patients with
depression who fail to initiate treatment in a timely manner. The intervention will be developed with the input of
patients in the target racial and ethnic minority populations and providers. Approximately 400 eligible patients
in two MHRN health systems will be randomized to the intervention group or usual care. Outcomes (treatment
initiation and rates recorded depression remission and response) will be ascertained from health system
records. Analyses will examine intervention participation and compare the primary outcome (treatment
initiation) and secondary outcomes (recorded depression remission and response) between groups. Results
will inform a subsequent full-scale pragmatic trial to assess reduction in population-level disparities.